Resveratrol treatment in monkeys

Following baseline data collection, the twenty-four rhesus monkeys were divided into treatment groups. Twenty of the monkeys were fed an obesity-inducing diet high in fat and sugar;ten of these monkeys received 40 mg resveratrol twice a day, ten monkeys got a placebo. Four monkeys remained on a healthy weight stable diet without resveratrol to serve as controls. Monkeys were monitored regularly and follow up data collection occurred at 3, 6, 9, and 12 months. At 12 months, the resveratrol dose was increased to 240 mg twice a day. Every three months for the following year, the monkeys were tested on the same variables. Data variables include body composition, glucose tolerance test, immune function, eye exams, pulse wave velocity, locomotor activity, learning and memory, and blood chemistry. The monkeys were sacrificed after 2 years on study and tissue samples were collected, processed and preserved. Analysis of all the tissue is ongoing. Preliminary data indicate that resveratrol had a protective effect for cardiovascular measures. Studies are ongoing.